Linking interneuron-mediated circuit regulation with sleep-dependent plasticity and memory storage in the hippocampus

Project summary: Synaptic plasticity in brain structures like the hippocampus has been hypothesized to
underlie an essential brain function - consolidating transient experiences into long-lasting memories. The
importance of sleep for promoting long-term memory storage, and the disruptive effect of sleep deprivation on
memory, have been appreciated for nearly a century. However, it remains unclear how sleep-associated
changes in the activity of specific brain circuits contribute to synaptic plasticity in the hippocampus and other
structures. The studies proposed here will test a novel hypothesis – that sleep and sleep loss differentially affect
memory consolidation through their differential effects on separate subpopulations of hippocampal interneurons.
We will use a simple behavioral paradigm for studying sleep-dependent memory consolidation in mice
(contextual fear memory; CFM) in combination with state-targeted pharmacogenetic and optogenetic
manipulations of parvalbumin-expressing (PV+) and somatostatin-expressing (SOM+) hippocampal
interneurons. In the context of these experimental manipulations, we will measure downstream effects on sleep-
associated CFM consolidation, hippocampal network activity, microcircuit-level changes in neuronal structure,
and biochemical changes in genetically-defined cell populations. We will first assess the effects of learning itself
(contextual fear conditioning; CFC) and subsequent sleep or sleep deprivation (SD) on neuronal morphology
using cell type-specific Brainbow labeling, and intracellular processes using cell type-specific translating
ribosome affinity purification (TRAP). We will then determine how state-specific manipulations of hippocampal
PV+ interneuron activity (which disrupt of rescue sleep-dependent CFM consolidation) affect these sleep-
dependent processes. Finally, we will test the hypothesis that SD disrupts CFM consolidation by selectively
activating SOM+ interneurons in the hippocampus, leading to suppression of activity in neighboring neurons. We
will test whether pharmacogenetic activation of these neurons (mimicking effects of SD) disrupts CFM
consolidation in freely-sleeping mice, and whether inhibition of these neurons during SD (mimicking effects of
sleep) rescues CFM consolidation. We will then assess the effects of changing SOM+ interneuron activity levels
on post-CFC changes in hippocampal network activity patterns, neuronal morphology, and cell biology. Together,
these studies will test the necessity and sufficiency of state-dependent activity in defined hippocampal neuron
populations for long-term storage of new memories.

Public health relevance
PROJECT NARRATIVE The proposed studies will provide new insights into how sleep uniquely contributes to long-term memory formation. This work has the potential to lead to targeted interventions for cognitive dysfunction induced by sleep loss, and interventions for psychiatric disorders where both sleep and cognition are adversely affected, including schizophrenia, depression, autism, and dementia. PHS 398/2590 (Rev. 06/09) Page 1 Continuation Format Page